Understanding Cognitive-Academic Bidirectionality in Math Learning Disabilities

PROJECT SUMMARY/ABSTRACT
Despite important advances in the treatment of learning disabilities (LDs), the dominant approach to
intervention—direct skills instruction—fails to meet the needs of 25-45% of LD students. This indicates the
need to expand the framework for LD intervention science with innovative approaches. This clinical trial (CT)
assesses the effects and mechanistic processes of an innovative approach to intervention guided by
cognitive-academic mutualism theory, in which cognitive resources support development of academic
competencies while academic tasks in turn exercise & strengthen cognitive abilities. The CT’s innovative
intervention provides coordinated cognitive training & direct skills instruction with supports for transfer
across domains. The academic focus is math: word-problem solving & arithmetic, both critical foundational
skills. The cognitive focus is working memory (WM) because WM plays a central role in early math
development. Participants are 6–8 years old, a critical age when WM malleability & beneficial effects
between emerging skills are rich in opportunity and when school instruction on the targeted math
competencies intensifies. Also, delays that remain at the end of 1st grade forecast math LDs. First-grade
children selected for math delays and low WM are randomly assigned to: (1) standard-of-care direct skills
math treatment + coordinated computerized WM training (the innovation; CO-Tx); (2) the same standard-of-
care direct skills math treatment + the same amount of computer game-like instructional activities not
involving WM or math (the contrast standard-of-care condition); & (3) control group (the conventional school
program & maturation; CON). Treatment occurs 3 times per week for 15 weeks. The primary outcomes are
word-problem solving, arithmetic, & WM. Innovative intervention’s added value over standard-of-care direct
skills math treatment (without WM training) is tested at posttest & delayed posttest, with 1-year follow-up
effects explored. Mechanistic processes are assessed by testing whether bidirectional relations between
WM & math are involved in the mediation pathway linking CO-Tx’s effects on delayed posttest math & WM
and whether CO-Tx’s bidirectional relations are stronger in CO-Tx than in other conditions. Exploratory
subgroup analyses are conducted to provide insight into the robustness of effects. This CT impacts
science by deepening understanding about the potential for treatments based on cognitive-academic
mutualism theory to enhance learning more than conventional direct skills instruction and deepening
understanding about bidirectional relations between WM and early math development. Results may impact
clinical practice by providing an innovative approach for treating math difficulties and other forms of LD.
This CT is highly relevant & significant because math LDs are associated with long-term debilitating
difficulty in school, the workplace, and everyday life and because pressing need exists to expand the
framework for treating LDs with innovative approaches.

Public health relevance
PROJECT NARRATIVE Math learning disabilities (MLDs) occur frequently and are associated with difficulty in school, the workplace, and everyday life. Yet, the dominant approach to treatment—direct skills instruction—fails to meet the needs of a substantial proportion of these children. This creates a serious public health problem and a pressing need to expand the framework for MLD treatment with innovative approaches, like the approach tested in this clinical trial.